CORE--HEALTH ASSESSMENT

This Core will provide health assessments at four separate time points for project 0002 and 0004 including current health status and intercurrent events. The Core will also conduct pharmacotherapy compliance assessments including automated micro-chip MEMS Track Cap Measurements, pharmacy record review, pill counts, and subject self reports. Another core responsibility is to conduct aerobic fitness assessments for subjects entered into the exercise/psychophysiological studies in Project 0005. The Core will also conduct qualitative urine screens and collect blood for assessing viral load and immune measures during each health assessment visit.